Next Generation GPC2-CARs for Medulloblastoma

Project Summary
Progress against pediatric solid tumors has stalled. Current standard therapies largely employ dose intensive
cytotoxic agents developed in the 1970s and 1980s that incur severe lifelong toxicity and are unable to cure most
patients with high-risk, metastatic, recurrent or refractory disease. Medulloblastoma (MB), the most common
malignant brain tumor of childhood epitomizes this reality, since standard therapies are exceedingly toxic and
outcomes for patients with metastatic, recurrent or refractory disease remain poor. There is an urgent need for
novel, effective targeted therapies for MB. Cerebroglycan (GPC-2) is overexpressed on the cell surface of MB
and is not expressed on normal postnatal tissues rendering it a compelling target for treatment with chimeric
antigen receptor (CAR) based therapies. CAR based therapies have shown impressive activity in B-cell and
plasma cell malignancies, and early signals of activity have been observed with GD2-CAR T cells in children
with diffuse midline glioma and neuroblastoma respectively, providing evidence that CAR T cells can mediate
significant activity in pediatric brain tumors and solid tumors. In stringent preclinical models, we demonstrated
that an iteratively optimized GPC2-CAR mediated significant antitumor activity in MB and NB, but also observed
late disease recurrence associated with GPC2 downmodulation. Leveraging deep expertise in enhancing the
potency of CAR T cells in the Mackall lab, we demonstrated that overexpression of cJUN in GPC2-CAR T cells
led to improved long-term disease control against MB and NB without evidence for toxicity. These data align
directly with studies from our lab and others demonstrating that cJUN overexpression lowers the antigen density
required for CAR T cell activation, diminishes T cell exhaustion and enhances T cell persistence. Aims 1 and 2
of this Project will define the optimal approach to overexpress cJUN in GPC2-CAR T cells at clinical scale testing
state-of-the-art approaches to co-transduction, viral free gene integration and cell selection to identify the most
efficient and reproductible platform for consistently delivering an optimized clinical GPC2.cJUN-CAR product. In
Aim 3 we will apply the optimal process to manufacture clinical grade GPC2.cJUN-CAR T cells in Arm B of a
Phase I trial designed to assess the feasibility, safety and efficacy of GPC2.cJUN-CAR T cell therapy against
MB. This trial will compare outcomes between patients treated with GPC2-CAR T cells that did not overexpress
cJUN who will have previously been enrolled on Arm A. This work will be among the first to test a potency
enhanced CAR T cell therapy for pediatric cancer, will provide valuable information about the promise of GPC2
as a target for MB and will provide preliminary evidence regarding whether cJUN OE can enhance CAR T cell
potency without incurring significant toxicity in humans.

Public health relevance
Project Narrative Medulloblastoma (MB) is the most common malignant brain tumor occurring in children. Stanford therapies are non-targeted and exceedingly toxic and outcomes for children with relapsed/refractory MB are very poor. This proposal will develop and test a novel, potency enhanced GPC2-CAR T cell therapy that shows impressive efficacy in preclinical models of MB in patients with relapsed/refractory MB.